Administrative Equipment Supplement for Ultracentrifuge and Rotor Package

The current R01 (5R01GM139977-02) is eligible for acquisition of a new ultracentrifuge and
rotor package. The grant is active with the second year of funding starting on 3/1/2023. The
grant will be active for four years from the time of this request, through 2/28/2027. This is a one-
time request for equipment that is less than the amount of one year of funding.

Public health relevance
Narrative: The protein synthesis machinery has long been recognized as a therapeutic target of vast potential. The eukaryotic translation initiation factor 4B promotes a protein synthesis program that opposes both metastatic behavior in cancers and activity of other initiation factors in cells; hence, our work determining mechanisms by which eIF4B operates and is regulated could open new avenues for early detection and treatment of cancer and other diseases.